Addressing social adversity to improve outcomes among children undergoing liver transplant: the role for a health advocate on the transplant team

PROJECT SUMMARY .
Pediatric liver transplantation is a life-saving procedure for children with end-stage liver disease, yet long-term
outcomes remain sub-optimal. Children facing social adversity, and those from socioeconomically deprived
backgrounds have increased risk of graft failure and death following transplant. Disparities in post-transplant
outcomes are well-known, yet the field has thus far been unable to overcome them. In contrast, pediatric
primary care is rapidly evolving to develop assessment of specific social risk factors and integrate efficacious
interventions to address material economic hardships (e.g., food insecurity), poor health literacy, caregiver
mental health, social isolation, and neighborhood environment. One potential strategy, utilized in other fields, is
to incorporate Health Advocates (team members who help patients/families address social risks) into the
clinical team. To adapt a Health Advocate intervention to the needs of children undergoing liver transplantation,
a more nuanced understanding of which children are at highest risk, and how a health advocate could integrate
within the transplant team are needed. To that end, this study will leverage Dr. Wadhwani’s ongoing KL2
funded, multi-center prospective cohort (SOCIAL-Tx) across 8 U.S. transplant centers to achieve the following
Aims: (1) Characterize the association between social risks at the time of transplant with adverse outcomes at
1 and 3 years after transplant; (2) Use multi-stakeholder qualitative interviews (patients/families, physicians,
nurses, social workers) to characterize barriers and facilitators to optimal transplant care for patients/families
with social risks; (3) Assess feasibility of integrating a health advocate into a liver transplant team and pilot a
single-center study exploring whether targeted social support improves post-transplant outcomes. These Aims
will provide the necessary preliminary data for a future clustered, pragmatic multi-center RCT testing this
Health Advocate intervention. Dr. Wadhwani is an Assistant Professor of Pediatrics at the University of
California, San Francisco. Building upon a strong foundation of research support, this K23 award will establish
him as an independent health services researcher pioneering research at the intersection of pediatric
hepatology, transplantation, and social determinants of health. Under the direct supervision of a
multidisciplinary team of leaders in liver transplant/multi-center cohort building (Jennifer Lai), pediatric
hepatology, and multi-center clinical trial design (John Bucuvalas), social care integration into health systems
(Laura Gottlieb), and qualitative and implementation science methods (Courtney Lyles), Dr. Wadhwani will
execute a detailed career development plan to achieve 4 training goals: (1) Pioneer a research niche
integrating social and medical care for children undergoing liver transplantation, (2) Develop expertise in social
adversity measurement and assessment, (3) Acquire skills necessary to develop, test, and implement health
system interventions (e.g., multi-center prospective mixed-methodology, survey methods, in-depth
interviewing, and ethnography), and (4) Develop skills in multi-center study design.

Public health relevance
PROJECT NARRATIVE . The proposed research serves public health with its novel focus to improve pediatric liver transplant outcomes by assessing and intervening on children’s underlying health-related social risks, e.g., material economic hardship, social isolation, caregiver mental health, health literacy, and neighborhood characteristics. Integrating a Health Advocate as a member of the post-transplant care team will support the delivery of interventions to overcome barriers interposed by these social risks, with clear potential to close disparities and significantly improve long-term outcomes for these children. The proposed research is directly relevant to NIDDK’s vision to seek insights and answers to bridge health disparities.